Modern approach to electrical conductivity mapping of spinal cord tissues

Project Summary
Over 30,000 patients per year receive electrical stimulation of the spinal cord (neuromodulation) as a means of
pain management. However, optimizing the delivery parameters is difficult, partly because of an extremely
valuable but incomplete dataset on the electrical conductivity of spinal cord tissues. We traced the lineage of
the spinal tissue electrical conductivity sources of the majority of modern electrostimulation models to a single
source,
Ranck 1965. The experiments within Ranck 1965 only provided two types of data: (1) bulk spinal tissue
conductivity at 5, 50, 500, and 5k Hz; and (2) small volume (8 mm3) of dorsal column tissue conductivity at 5-10
Hz. Since the distribution of spinal cord cells throughout the cord is not uniform, the bulk spinal tissue
conductivity sweep does not provide enough spatial information for a detailed electrical model between different
sections, layers, and tissue types of the spinal cord. Our project seeks to significantly improve on Ranck 1965
by obtaining 10-1M Hz, large-volume (40 cm3), and multi-directional conductivity data for electromagnetic
modeling of neuromodulation using an electronically-controlled conductivity probe array. With our findings,
neuroscientists and neuromodulation researchers and designers will be able to provide more targeted therapies
as a result of a more-detailed and rigorous electromagnetic spinal cord model.

Public health relevance
Project Narrative Over 30,000 patients per year receive electrical stimulation of the spinal cord (neuromodulation) as a means of pain management. However, optimizing the delivery parameters is difficult, partly because of an incomplete dataset on the electrical properties of spinal cord tissues. Our project seeks to significantly improve on previous exploratory conductivity datasets by providing multi-frequency, multi-location, and multi-directional data for electromagnetic modeling of neuromodulation.